Frequency domain speckle tracking for OCT based 3D vibrometry of the inner ear

The increasing prevalence of hearing loss is driving the demand for improved techniques to study the intricate
structure and complex processes of the living cochlea. Optical coherence tomography (OCT) has become a
widely used technology to study the vibrometry of the living cochlea due to its temporal and spatial resolution.
One limitation with OCT is that it only measures the vibratory response of the cochlea along its optical axis,
providing measurements in just one dimension. Given that the cochlea has a 3D structure with subcellular
structures that move in all 3 dimensions when stimulated, traditional OCT does not capture important
information about the full range of movement of the cochlea.
To address this limitation with OCT, our lab has built a 3-beam OCT and vibrometry system that has three
sample arms combined at a single interferometer. With three projections of data collected from three different
angles, we can reconstruct the 3D vector of motion when the living cochlea is excited. We have used this system
to collect data from the apical region of the mouse cochlea and study the 3D motion for different stimuli.
However, it is not ideal as it is a complex optical system to develop, and it requires precise co-registration
making it challenging for other labs to reproduce.
In this proposal, we are developing a new approach to study the 3D motion of the cochlea that involves
extracting the vibrational angles encoded in OCT image stacks collected using a traditional OCT system. By
scanning our sample at higher frame rates, we can obtain sequential cross-sectional images in the XZ and YZ
planes and extract the corresponding vibrational angles. With this information, we can compute the 3D motion
vector through the vibration-based modulation of the image’s spatial frequencies. We have validated this
approach for low frequencies using a piezoelectric phantom with a layer of scattering material. However, we
want to extend this approach to work for higher frequencies so we can collect measurements from the apical
region of the mouse cochlea (2 kHz-15 kHz). Obtaining 3D vibrometry from the mouse cochlea using a more
accessible approach with a traditional OCT system will enable our lab and others to build on these studies.
In Aim 1, we will be implementing changes to the acquisition of our OCT system to be able to perform
interleaved sampling. This will allow us to use our approach for our target frequency range of 2 kHz to 15 kHz.
We will validate these changes using a position sensor to check the scan pattern and piezo experiments to
ensure we can use our speckle approach at the desired frequencies. These validation experiments will give us
the confidence to move forward with Aim 2, where we will use our speckle approach to measure the 3D motion
vector for different structures within the mouse cochlea. We will compare the measured 3D vector of motion
from vibrometry points taken from the tectorial membrane, reticular lamina, outer hair cells, inner hair cells,
and basilar membrane to our current results with the 3-beam OCT system.

Public health relevance
PROJECT NARRATIVE Hearing loss is increasingly prevalent in the United States, currently affecting 60.7 million American people over 12 years of age. Optical Coherence Tomography (OCT) is the only imaging modality with the resolution necessary to capture detailed images of the morphology and vibratory motion of structures in the inner ear, specifically in animal models of hearing. By leveraging the capabilities of OCT, we will be able to study the 3D cochlear mechanics of mice for the first time through this proposed research work, providing valuable insights into potential preventative and curative therapies for hearing loss in humans.